Ethnic-specific Effects of Mitochondrial DNA Variants and Environmental Factors on Cognitive Functioning and Dementia

Among U.S race/ethnic groups over 75 years of age, African Americans exhibit the highest cognitive impairment
prevalence (32%) followed by Hispanics (23%) and Non-Hispanic Whites (10%). Our proposal implements
multiple novel genomic tools designed to capture ethnic-specific targets of Alzheimer's disease (AD) and related
dementias (ADRD) within the mitochondrial DNA. A novel aspect of our proposal is that we can rapidly translate
human mitochondrial genetic associations into cellular and animal experimental paradigms and infer whether
these mtSNPs modify mitochondrial-derived peptides (MDPs), which are a group of micro-peptides that display
profound effects on metabolic and neurodegenerative disease processes. We provide evidence in this proposal
that we have already identified three mtSNPs in Non-Hispanic Whites, African Americans, and Hispanics that
associate with AD phenotypes in an ethnic-specific fashion through MDPs. In this proposal, we will conduct
several novel genetic analyses: (1) Mitochondrial Genome Wide Association Studies (MiWAS), (2) Mitochondrial
Genome Wide GxE and GxG Interaction Studies (MiWIS), and (3) mitochondria RNASeq differential expression
analysis (mito-transcriptomics), in three large, longitudinal multi-ethnic cohorts with comparable repeated
measures of cognitive decline as well as lifestyle and metabolic factors (e.g., body mass index, diabetes, and
physical activity). Using the Health and Retirement Study (HRS) and REasons for Geographic And Racial
Differences in Stroke (REGARDS) cohorts, we will conduct discovery MiWAS and MiWIS for Non-Hispanic
Whites (n~14,300), African Americans (n~13,400), and Hispanics (n~2,420). We will test replication of findings
from HRS and REGARDS on cognitive decline and diagnosis of clinical AD using the diverse Rush Alzheimer's
Disease Center (RADC) cohorts (n~4,500). We will conduct mito-transcriptomics for all ethnic groups in HRS
(n~4,000; white blood cells) and in RADC (n~640; brain prefrontal cortex). Our central hypothesis is that specific
mtSNPs and mitochondrial gene expression will predict clinical AD diagnosis and cognitive decline differently by
ethnicity. For this project, we have assembled an interdisciplinary team to: 1) Identify ethnic-specific mtSNPs
that predict cognitive decline, ADRD, and AD. 2) Identify ethnic-specific mtSNPs that interact with lifestyle factors
or nuclear SNPs to affect cognitive decline, ADRD, and AD. 3) Investigate whether genes that encode
mitochondrial-derived peptides are differentially expressed relative to AD or ADRD status in different ethnicities.
This project permits discovery of mitochondrial genetic targets that can be explored as precision-based,
ethnic-specific, potential ADRD treatment targets, in the form of micro-peptides derived from the mitochondria.
Findings from this proposal will be instrumental to AD therapeutic discovery because the makeup of the national
population is becoming more ethnically diverse.

Public health relevance
Alzheimer's disease (AD) and related dementias (ADRD), for which no effective therapy exists, affect millions of people in the US, cost hundreds of billions of dollars in caregiving expenses, and are a source of important racial and ethnic disparities. Education and lifestyle contribute to these disparities, and this project will clarify how genetic factors may also be involved through the application of three novel tools to study mitochondrial genetic variation: 1) mitochondrial genome-wide association studies (MiWAS), 2) mitochondria-wide gene and environment (GxE) interaction scans (MiWIS), and 3) mito-transcriptomics. The proposed analyses will help explain ethnic differences in AD risk and guide immediate diagnostic insights, targeted lifestyle interventions, and novel therapeutic target identification.